Administration and Management (Core 3) (pp 329-362)

The successful administration and management of the National Resource for Translational and Developmental Proteomics (NRTDP) is a critical component for its realization. Herein we describe the two overarching aims that will drive our efforts throughout the lifetime of the resource. Specific Aim 1: To provide the infrastructure for a multidisciplinary resource, integrating technology development, community-driven problem solving, and service to the scientific community through training and dissemination of the developed methods and research outcomes. Here, we describe strong institutional support and a mature team, well prepared to meet the challenges of running a National Resource. Specific Aim 2: To reduce barriers and increase the pace of research. Here we discuss the ongoing selection of new projects, strategies and tactics to maximize the impact of the NRTDP on a national scale. As described, to achieve these aims we will utilize our strong relationship with the administration at Northwestern as well as its investment and commitment to the resource. We have assembled a highly qualified, dedicated team that under the leadership of the Director, who will manage and coordinate the TR&D project leaders, oversee the progress and turnover of DBP projects, and ensure proper access to resource resources through Collaboration and Service, Training and Dissemination activities. We describe the development of efficient operating procedures that ensure integration and reduce barriers to rapid pace of research.